Development and Commercialization of Sialoglycan-Recognizing Probes

Project Summary/Abstract
Sialoglycans or Sias, which are abundant on cell surfaces and in secreted molecules, play key roles in various
biological processes, interact with both commensals and pathogens, and change over time in response to
environmental signals. However, most of this complexity and variation remains poorly characterized by traditional
techniques, using plant lectins, sialidases or antibodies, whose preferences are limited and/or uncertain.
Meanwhile mass spectrometry methods can overlook crucial aspects of Sia diversity and/or fail to elucidate
native Sia structures in biological systems. To address these challenges, the U01CA199792 grant supported by
the NIH Common Fund Glycoscience Program took advantage of naturally evolved microbial molecules
(bacterial adhesins, toxin subunits and viral hemagglutinin-esterases) that can recognize sialoglycans with
defined specificity. Multiple classes of Sialoglycan Recognizing Probes (SGRPs) with specificity defined by
sialoglycan microarray studies were engineered as tagged probes, each with a corresponding non-binding
mutant as a negative control. The optimized panel of SGRPs can be used in methods common in most
bioscience labs, such as ELISA, western blot, flow cytometry and histochemistry. In Phase I, we propose
continued development and validation of six SGRPs (SGRP1, SGRP2, SGRP3, SGRP5, SGRP6, and SGRP8).
We will reproduce SGRP1, SGRP2, SGRP3, and SGRP8 based on previously established methods and further
validate and optimize their applications in various laboratory techniques across diverse biological sample types.
SNA, a plant-derived lectin, was selected as SGRP6 due to its unmatched specificity for α2-6 sialoglycans. Since
no other microbial molecules surpass its specificity, we will develop a recombinant SNA protein with an AviTag
to overcome the limitations of the plant-derived form, ensuring consistent and reproducible production. We will
also develop a non-binding mutant control for the recombinant SNA. SGRP5 is an affinity-purified chicken IgY
polyclonal antibody against Neu5Gc sialoglycans, which is limited for long-term use due to finite supply and risk
of future non-reproducibility. We propose to develop chicken IgY monoclonal antibodies targeting all common
forms of Neu5Gc sialoglycans, providing a more durable and reproducible solution for routine use. In Phase II,
we will further develop and optimize SGRPs (SGRP4, SGRP7, and SGRP9) that specifically recognize 4, 7, and
9-O-acetylated sialoglycans, which are common modifications present in many mammalian cells. SGRP probes
could revolutionize the analysis of sialoglycans by making it simpler, more efficient, affordable and accessible,
allowing nonexperts using common laboratory techniques to find interesting sialome patterns in biological
systems. They also provide tools for real-time monitoring of glycosylation patterns in biopharmaceutical
production, ensuring consistency and quality. Our goal is to ensure these probes become readily available to the
research community, driving progress across multiple biomedical disciplines.

Public health relevance
Project Narrative Sialoglycans play critical roles in biological processes and disease, yet their study is hindered by their complexity and the limitations of current detection methods. This project aims to develop and commercialize a series of Sialoglycan Recognizing Probes (SGRPs) that leverage the sialoglycan-binding properties of naturally evolved microbial molecules. These probes will enable researchers to efficiently analyze patterns of intact sialomes, defined by specific sialic acid forms and linkages, across various biological samples using common laboratory techniques.